Positive and negative reinforcement pathways underlying sleep and alcohol use associations

PROJECT SUMMARY
Significance: Sleep disturbances are related to increased alcohol use (AU) and alcohol problems. The
mechanisms that account for this association are not well understood. The proposed study will be the first to
examine an integrative model including both a positive reinforcement pathway (i.e., higher impulsivity and
increased sensitivity to the stimulating effects of alcohol) and a negative reinforcement pathway (i.e., higher
anxiety and increased sensitivity to the anxiolytic effects of alcohol) that may link sleep disturbances and
alcohol problems. We will use a rigorous multi-method approach that extends the laboratory into the real world.
Results may directly inform AU treatment by identifying which specific sleep factors contribute to risk and why.
Aims: For the positive reinforcement pathway, we hypothesize that later sleep timing and shorter sleep
duration will predict higher impulsivity and greater increases in impulsivity and stimulation while intoxicated. For
the negative reinforcement pathway, we hypothesize that lower sleep efficiency, a marker of insomnia, will
predict higher anxiety while sober and increased anxiolytic response to alcohol. These processes will account
for the association between sleep factors and concurrent and prospective AU outcomes. Specificity of the
positive and negative reinforcement pathways will be examined. We will also explore if sex or diagnostic status
(alcohol use disorder (AUD), sleep disorders) moderate the relationships between sleep characteristics and
reinforcement pathways to AU. Approach: Young adult drinkers (21-30 years of age; 50% female; N = 150)
will complete a protocol that includes ecological momentary assessments (EMA), laboratory sleep and alcohol
response assessments, and 6-month follow-up. Participants will be current heavy episodic drinkers (i.e., 5+
days in past 30 days of consuming 5+/4+ for males/females; SAMHSA) to ensure sufficient range in alcohol
outcomes of interest. We will use two 10-day EMA/actigraphy protocols to track daily sleep characteristics
(timing, duration, and efficiency), anxiety, AU (freq. of 5+/4+ drinks/occasion), impulsivity, and subjective
alcohol response in the real world. Each EMA protocol will conclude with an overnight sleep laboratory
assessment followed by a within-subjects laboratory alcohol administration (counterbalanced: placebo/alcohol
sessions) to examine alcohol response. During the chronobiology lab visits, we will use salivary DLMO to
assess physiological circadian timing. During the alcohol lab visits, we will measure positive and negative
reinforcement pathways via subjective response (stimulation/anxiety) and impulsivity (self-report, tasks). A 90-
day timeline follow-back interview delivered 6 months later will allow for the prospective examination of
associations between sleep characteristics and later AU (freq. of 5+/4+ drinks/occasion) and problems. The
proposed study will provide novel information about how sleep disturbances, a set of modifiable factors, affect
alcohol response and impulsivity. These findings may directly translate to prevention/treatment efforts for AUD.

Public health relevance
PROJECT NARRATIVE Sleep disturbances are related to increased alcohol use and alcohol problems, but limited research has examined why these associations exist. The proposed project examines positive (increased impulsivity and sensitivity to the stimulating effects of alcohol) and negative (increased anxiolytic effects of alcohol) reinforcement processes that may increase the amount of alcohol consumed per occasion and ultimately alcohol problems for individuals with sleep disturbances. Results of the project can help inform intervention and prevention efforts that target sleep factors that may ultimately lead to a reduction in alcohol problems and alcohol use disorder.